RADx-UP SAY YES COVID Test Study (S4)

This supplement will follow the approved Abstract under RADx-UP 3U24-MD016258-01S1. As requested by the NIH, we will deploy the SAY YES! COVID Test pilot in two additional communities likely to experience surges in SARS-CoV-2 infections. These additional communities will not be subject to the sub-study.

Public health relevance
At home testing will provide answers to questions regarding community transmission for the SARS-CoV-2 pandemic as well as additional questions relevant for the implementation of public health intervention in future pandemics.